Neural connectivity before and after each of the three treatment phases of trauma-focused therapy for adolescent posttraumatic stress

PROJECT SUMMARY
Posttraumatic stress disorder (PTSD) during adolescence negatively impacts brain networks underlying
cognitive, social, and emotional function. Early intervention is important for mitigating long-term effects, but
about 20% of youth do not improve sufficiently with current approaches. By identifying the neurobiological
mechanisms of effective therapies, we facilitate the development of novel or personalized treatment
approaches for youth with PTSD. However, there has been limited progress in identifying the neural
mechanisms of treatment using neuroimaging, partly because most studies collect neuroimaging data at only
baseline and end-of-treatment, which collapses across multiple parts of the therapeutic process. The objective
of the proposed study is to take a new approach by identifying neural mechanisms associated with specific
phases of trauma therapy for youth with PTSD. Our central hypothesis is that each phase produces specific
brain changes that reflect the acquisition of skills and experiences occurring during that phase. Trauma-
Focused Cognitive Behavioral Therapy (TF-CBT) is evidence-based and widely-used to treat children and
adolescents with PTSD. It consists of 3 well-defined phases, providing an opportunity to test our hypotheses
with neuroimaging: changes in executive control networks will occur during the skills phase, changes in limbic
networks during the narrative phase, and changes in default mode networks during the consolidation phase.
To test these hypotheses, we will recruit N=180 girls and boys, ages 12-17, who have PTSD following
interpersonal trauma, such as physical abuse, sexual abuse, or witnessing violence. We will use a randomized
controlled trial design to assign participants to either TF-CBT (provided by study team clinicians who meet
fidelity standards and receive consultation from Dr. Judith Cohen, the treatment developer) or Treatment as
Usual (TAU; provided in the community and does not follow a phased structure). We will collect functional
magnetic resonance imaging (fMRI) data before and after each of the 3 phases of TF-CBT or the same time
intervals of TAU. Individual differences in age, sex, dissociative subtype, symptom severity and other variables
will be investigated as covariates of phase-related neural changes. Analyses will identify the phases of TF-
CBT for which brain regions and networks change for the TF-CBT but not the TAU group. We will also identify
the phase(s) that best predict end-of-treatment symptom improvement. Exploratory analyses will use
neuroanatomical and white matter diffusivity scans to identify co-occurring changes in brain structure. The
proposed innovative study will provide novel information on the neurobiological and cognitive mechanisms
associated with the process of trauma therapy for youth with PTSD.
1

Public health relevance
NARRATIVE Posttraumatic stress disorder in adolescence impairs neurobiological networks underlying cognitive, social and emotional skills. Neuroimaging research that seeks to identify the neural mechanisms of treatments for PTSD could lead to novel treatments, but progress has been slow using current methods. The proposed study uses an innovative approach to identify neural mechanisms of specific phases of trauma-focused therapy for youth with PTSD, allowing a new understanding of brain changes associated with the process of therapy.